Patient-Directed Computational Analysis of Atrial Fibrillation

Patient-Directed Computational Analysis of Atrial Fibrillation
Project Summary
Atrial fibrillation (AF) poses a significant and rapidly escalating health challenge, impacting over 5 million
Americans and contributing to heightened risks of stroke, heart failure, and mortality. Despite extensive
research efforts spanning decades, the precise mechanisms underlying AF remain incompletely understood,
leading to suboptimal therapeutic interventions. Recent investigations, however, have shed light on the role of
rotational or focal activity in driving AF, with targeted ablation of these sources showing promise for long-term
outcomes. Yet, due to the complexity of AF and limitations in visualization, targeted ablation approaches do not
consistently yield successful results.
This project aims to advance our understanding of AF mechanisms and enhance therapeutic strategies for AF
management. A key focus will be the development of a novel analysis technique capable of generating easily
interpretable visual maps depicting the electrical activation patterns in AF patients. Leveraging a large and
unique database of AF patient data, this technique will retrospectively analyze AF activity to elucidate how it is
organized in these individuals. Additionally, extensive simulations will be conducted using patient-specific
anatomical models to explore how atrial anatomy influences AF dynamics.
The significance of this project lies in its potential to increase our understanding of AF and uncover novel
mechanisms underlying AF maintenance. The insights gained can directly inform clinical practice and facilitate
the development of more effective treatment options, ultimately improving outcomes for individuals with AF.

Public health relevance
Project Narrative Atrial Fibrillation (AF) is the most common cardiac arrhythmia in the world and increases the risk of stroke, heart failure and other heart-related complications. Ablation is increasingly used to treat AF but is not always successful. In this study, we will develop novel computational methods to analyze the dynamics of AF, which can be employed to better target ablation. Our study may provide useful clinical tools to improve ablation procedures in AF patients.